Prospective impact of media use on sleep and obesity risk in preschoolers

PROJECT SUMMARY
Preventing overweight in preschoolers may be an effective way to reduce the lifetime risk of obesity. Though
adequate, quality sleep is increasingly recognized as essential for maintaining a healthy weight, the risk factors
for insufficient sleep in preschoolers are poorly understood. While media use has been associated with
insufficient sleep in preschoolers, most studies are limited because of unmeasured confounding related to
household chaos and a sole focus on total media use quantity or bedroom media use without considering media
content. Furthermore, insufficient sleep likely leads to overeating in adults, yet few studies have considered that
effect in preschoolers. My long term goals are to become an expert in how preschoolers engage with media and
how media use impacts sleep and obesity risk, while emphasizing the use of wearable devices to objectively
measure media use and sleep. My objectives for this mentored research scientist development award are thus
to become an expert in 1) conducting prospective research studies on obesity prevention in early childhood, 2)
media use behaviors in preschoolers, 3) using wearable devices to objectively measure media use and sleep in
preschoolers, and 4) mastering advanced statistical methodology needed for establishing causal inference in
health behavior research. I will complete my training with coursework, participation in the plenary sessions,
workshops and short-­courses at targeted scientific meetings, and through the completion of a novel, prospective
research study to examine the causal relationships between media use, sleep, overeating and weight gain in
preschoolers. My research is particularly novel because I consider how the content of media preschoolers
engage with modifies the relationship between media use and sleep. My innovative research design accounts
for household chaos with a validated measure, includes the novel application of a valid, wearable audio recording
device to objectively measure media exposure, and includes a laboratory-­based assessment of overeating (i.e.,
eating in the absence of hunger) to define the association of nighttime sleep on subsequent overeating.
Importantly, my program will be conducted under the guidance of an expert mentorship team that consists of a
pediatrician and behavioral epidemiologist (Dr. Sargent), an epidemiologist in early child health (Dr. Karagas), a
behavioral researcher in early childhood obesity prevention (Dr. Benjamin Neelon), and a statistician in
behavioral research (Dr. O’Malley), as well as three advisors with specialized training in sleep and child eating
behaviors. In Year 5 I will submit an R01 proposal for a prospective study properly powered to define the causal
relationships between media use and excess weight gain while considering mediating and moderating factors.
This line of research will substantially advance the understanding for how preschoolers engage with media and
how that use impacts sleep, and ultimately, obesity risk. With my strong quantitative background and
documented success as an early investigator, I have no doubt I can lead this exciting and novel area of research.

Public health relevance
PROJECT NARRATIVE Insufficient sleep is a major risk factor for obesity. This study proposes exciting research to rigorously measure the causal associations between media use, insufficient sleep, overeating and weight gain in preschoolers, while incorporating objective measures. I also test novel hypotheses to determine how characteristics of media content, independent of total media time, impact sleep in preschoolers. This line of research can ultimately inform media- use interventions to improve sleep among preschoolers.